Empowering cancer detection and monitoring with CampEx - CRISPR-accelerated molecular profiling of Extracellular vesicles

Extracellular vesicles (EVs) have emerged as potent analytes in liquid biopsy, presenting diverse molecular
cargo that can potentially inform somatic mutations, resistance proﬁles, and tumor recurrence. However, EVs
remain underutilized in clinical assays due to technical challenges. Tumor-derived EVs comprise a small
fraction (<5%) of total circulating EVs, and the marker contents in EVs are often very low (e.g., mRNA).
Consequently, current EV analyses necessitate large sample volumes (>2 mL plasma) and sophisticated
resources. Innovation. We aim to address these limitations by advancing CampEx (CRISPR-accelerated
molecular proﬁling of extracellular vesicles), an integrated platform for EV molecular analyses with exquisite
sensitivity and precision. CampEx embodies our new breakthrough in CRISPR-based biosensing: CRISPR-
associated (Cas) proteins ﬁrst recognize their speciﬁc mRNA target, an event that triggers RNA replication and
signal ampliﬁcation. This unique mechanism enables CampEx to differentiate between single-nucleotide
polymorphisms while achieving a detection limit in the sub-attomolar ranges. Goals. Our recent study validated
the CampEx concept in pre-clinical and clinical samples. Building on these promising results, we aim to
advance CampEx to a robust, clinically translatable diagnostic platform. We seek two complementary
objectives: i) enhancing CampEx's analytical capabilities to enable high-throughput and comprehensive EV
analysis and ii) rigorously evaluating EVs' value for precision oncology. Aim 1. We will expand CampEx's
analytical targets (>40 markers). The mRNA detection panel will include i) key driver genes and mutations that
account for >90% of cancer cases and ii) markers of chemotherapy resistance. Furthermore, we will
incorporate protein detection into the CampEx assay ﬂow, capitalizing on EVs' inherent advantage as multi-
cargo carriers. We will validate the designed probes, adhering to regulatory (FDA) guidelines to obtain
analytical statistics. Aim 2. We will implement a high-throughput, automated CampEx instrument capable of
performing 96 parallel measurements. This new system will incorporate our novel "digital modulation" strategy
to enhance the robustness of signal detection. Completing this aim will produce a practical system suitable for
routine laboratory applications. Aim 3. We will apply CampEx to analyze clinical plasma samples for early
tumor detection and treatment monitoring, focusing on two cancer types: ovarian cancer and colorectal cancer.
This study will determine CampEx's clinical assay performance, including sensitivity, speciﬁcity, and correlation
with clinical outcomes. To accomplish our goal, we have assembled an interdisciplinary team (biosensing, EV
biology, clinical research, bioinformatics) and clinical resources. Completing this project will establish CampEx
as an impactful platform, enabling multi-marker detection in a cohesive single platform. Ultimately, CampEx
will expedite preclinical and clinical readouts, thus augmenting EVs' clinical utility in precision cancer care.

Public health relevance
We will advance an integrated platform for ultrasensitive molecular screening, termed CampEx for Crispr- accelerated molecular proﬁling of Extracellular vesicles (EVs). CampEx harnesses CRISPR-mediated recognition of molecular targets to initiate signal probe ampliﬁcation. This innovative strategy will allow CampEx to achieve a sub-attomolar detection limit while maintaining a rapid and convenient one-pot assay format. We will apply CampEx to analyze circulating EVs in blood samples from cancer patients, with the aim of monitoring EV phenotype dynamics during the course of therapy.